HETEROSEXUAL TRANSMISSION OF HIV TO PARTNERS OF DRUG ABUSERS

Steady heterosexual partners of hospitalized intravenous drug abusers and of patients in methadone programs will be studied.Seroconversion, development of disease and protective effects of condom use will be determined.